Insurance Mandate Generosity, COVID-19, and Health Care for Children with Autism

PROJECT SUMMARY
To reduce the unmet health care needs among children with autism spectrum disorders (ASD), one
state-level policy response has been legislations that require private health insurers to provide coverage for
ASD-related services, known as state autism insurance mandates. By 2019, insurance mandates were
enacted in all states and the District of Columbia. Several studies have documented substantial variations in
state autism insurance mandates. However, there is a paucity of evidence about whether children with ASD in
the states with more generous mandates have fared better than those living in the states with more limited
mandates. Identifying this evidence is of critical importance given the fact that children with ASD have complex
health conditions and require affordable, comprehensive insurance coverage to meet their health care needs
either under normal circumstances or during unusual times, such as the COVID-19 pandemic. It is also
unknown which specific mandate policy features matter most for reducing unmet needs among this group of
children and maintaining or increasing their health care utilization during the pandemic.
This proposed project aims to fill the evidence gaps by examining each of these issues. Our goal is to
contribute to the knowledge base that can inform decision-making on health care financing for children with
ASD. Specifically, we will carry out the following Aims: (1) Use national survey data to assess the extent to
which more generous state autism mandates improve health care access and reduce unmet needs for children
with ASD before the COVID-19 pandemic, (2) Use nation-wide insurance claims data to assess the extent to
which more generous state mandates increase service utilization and spending for children with ASD, by
setting (outpatient, ED, inpatient, home) and care type (medical, behavioral, pharmacy), before the pandemic,
and (3) Use both national survey and claims data to assess whether and to what extent more generous state
mandates help maintain or increase access, utilization, and spending for children with ASD from before to
during the pandemic.
To examine the Aims, we will adopt difference-in-differences and triple-differences approaches, both of
which are rigorous quasi-experimental designs. The proposed study is unique in examining how health care for
children with ASD is affected by the generosity of state mandates in general and by type of mandate policy
feature in specific. The proposed study is timely since its findings have the potential to inform policy-making on
expanding insurance benefits and closing coverage gaps for children with ASD as the nation fights the
pandemic and potentially embarks on new rounds of health system reform. Our study results will also be
relevant to broader debates around optimal design of essential health benefits, a topic of great interest to
policy-makers and researchers, especially in the past decade.

Public health relevance
PROJECT NARRATIVE While several studies have noted substantial variations in the generosity of benefit coverage required by state autism insurance mandates, there is little evidence on how the effects of insurance mandates vary by the generosity. This proposed study aims to fill the evidence gap by identifying which specific mandate policy features matter most for improving health care for children with autism. The study findings have the potential to inform policymaking on expanding insurance benefits and closing coverage gaps for children with ASD, and the findings will also be relevant to broader debates around optimal design of essential health benefits, a topic of great interest to policymakers and researchers, especially in the past decade.